ACTG 254--ATOVAQUONE/AZITHROMYCIN VS TMP/SMX TO PREVENT BACTERIAL INFECTION

This study will compare the safety, tolerance and efficacy of the combination of atovaquone and azithromycin to trimethoprim- sulfamethoxazole in the prevention of serious bacterial infections and the prophylaxis of PCP.